MINORITY CANCER CONTROL RESEARCH PROGRAM

In 1989, the UNC Lineberger Comprehensive Cancer Center and the Schools of Public Health and Medicine at the University of North Carolina at Chapel Hill (UNC) created the UNC Minority Cancer Control Research Program (MCCRP) to provide an organized framework for building collaborative minority health and cancer control research activities. Supported by an NCI Minority Enhancement Award, the UNC MCCRP has (1) carried out (a) developmental studies and minority components added to the existing cancer control projects and (b) research development to create new minority cancer control research opportunities and (2) contributed to the development of minority investigators. To date a total of nine projects have been conducted or are underway, in the areas of breast cancer screening, diet and cancer, and smoking cessation. These developmental studies have led to three peer-reviewed minority cancer control awards, one to an African American investigator. We now seek to continue and extend awards, one to an African American investigator. We now seek to continue and extend the UNC MCCRP by (1) launching two new studies targeting minority issues and populations and (2) continuing to support developmental research in two new areas. The two new projects are: l. Improving healthcare and quality of life in African American women with newly diagnosed breast cancer through extending a successful lay-health advisor program (Save Our Sisters) into the referral networks of medical oncologists and primary care physicians (years 1-3) 2. Evaluating implementation of a stage-based smoking cessation protocol for African American physicians, using the Pathways to Freedom Program (years 1-3) The developmental support will be used to develop new projects and new investigations in two areas: 1. Developing a culturally-congruent intervention to boost wheat bran fiber consumption in middle-aged African Americans (year l) 2. Developing a smoking cessation intervention for pregnant African American women and young mothers that addresses social support and optimistic bias in perceptions of the health risks of active and passive smoking (years 2-3). The proposed award will build on the existing foundation for a long-range, continuing program of minority cancer control research at UNC, by linking a team of investigators, many of whom are African Americans, with nationally recognized expert consultants.